THE OBJECTIVE OF THIS PROJECT IS TO PROVIDE SERVICES, PERSONNEL, EQUIPMENT AND FACILITIES AS REQUIRED TO PERFORM ANALYSIS OF BULK DRUG SUBSTANCES AND

The purpose of the project is to perform QC analysis of new lots of bulk drug, in compliance with FDA regulations.